Kinome-guided Targeting of Cooperative Dependencies in BRAF and KRAS Mutated Colorectal Cancer

Metastatic colorectal cancer (mCRC) is the second leading cause of cancer-related death in the US. Roughly
half of mCRCs harbor a mutation in BRAF or KRAS, associated with worse prognosis and fewer treatment
options. Results of clinical trials targeting components of the signaling cascades containing BRAF and KRAS
have been underwhelming. These findings signify that mCRC is not driven by a unique pathway or dominated
by a single oncogene. The objective of this proposal is to test the hypothesis that a critical set of
upregulated, parallel pathways function as cooperative dependencies, driving therapeutic resistance in
BRAF and KRAS mutated mCRC. New resources and technologies are required to accomplish this objective.
Thus, the proposed research will pair patient-representative specimens, including tumor samples and patient-
derived xenograft (PDX) models established by co-PI, Dr. Atreya, with a novel high-throughput kinase-activity
mapping (HT-KAM) platform developed by co-PI, Dr. Coppé. HT-KAM uses peptide libraries as combinatorial
sensors to directly measure the activity of kinase enzymes and reveal actionable vulnerabilities of kinase
pathways. Aims 1 and 2 will focus on BRAF(V600E) mutated mCRC. The starting materials for Aim 1 are
BRAF mutated mCRC PDX tumors treated with regimens received by corresponding patients on clinical trials,
or a BRAF inhibitor combined with agents targeting orthogonal modes of action, found by surveying CRC cell
lines with a pilot version of HT-KAM. Aim 1 will identify the conserved kinase-dependent pathways of BRAF
mutated PDX tumors. Kinase signatures will be established via a vastly expanded version of HT-KAM, and
computationally integrated into hierarchies of functional networks using the PhosphoAtlas blueprint of the
phospho-reactome built by Dr. Coppé. This will reveal which pathways and which specific dependencies are
most conserved. Aim 2 will test new combinatorial strategies to treat BRAF mutated mCRC, identified from
pilot studies and the kinome profiles of PDX tumors. Two- to four-drug strategic possibilities, directed at distinct
pathways, will be prioritized from candidate targets. Treatment hypotheses will be tested in cell lines and
synergy analysis will be performed. The most promising combinations will then be tested in BRAF mutated
mCRC PDX models. The regimens with the greatest efficacy will be optimized in anticipation of translation
back to patients. Aim 3 will focus on KRAS(G12) mutated mCRC. Preliminary data predicts that the functional
susceptibilities driving BRAF and KRAS mutated mCRC will differ. KRAS(G12) mutated mCRC offers the
opportunity to directly evaluate surgical specimens, and to develop corresponding PDX models. The same
iterative workflow as described for BRAF mutated mCRC will be applied to discover and target the cooperative
dependencies of KRAS(G12) mutated mCRC. The long-term goals of this project are to are: 1) to improve the
survival of patients via therapeutic strategies specifically tailored to BRAF or KRAS mCRC; and 2) to establish
a transformative discovery pipeline that is generalizable to any tumor type.

Public health relevance
Metastatic colorectal cancer harboring a BRAF or a KRAS mutation is associated with poor prognosis and limited treatment options, leading to approximately 400,000 deaths worldwide each year. We seek to identify and target the upregulated, parallel pathways that function as cooperative dependencies, causing therapeutic resistance, by profiling patient-derived tumor samples with an innovative kinase-activity mapping technology. Our long-term goals are: 1) to improve the survival of patients via therapeutic strategies specifically tailored to BRAF or KRAS mutated metastatic colorectal cancer; and 2) to establish a transformative discovery pipeline that is generalizable to any tumor type.